GENETIC ANALYSIS OF RHEUMATOID ARTHRITIS IN SIB PAIRS

Identify rheumatoid arthritis susceptibility genes. A centralized clinical database, DNA, serum and cell bank will be established for all affected sibling pairs and family members.